Genomics Core

PROJECT SUMMARY/ABSTRACT - GENOMICS CORE
The goal of our Program is to fill a critical gap in knowledge in understanding the molecular mechanisms that
control the development of human and mouse γδ T cells. To achieve this goal, the Projects within our Program
employ a variety of cutting-edge genomics approaches at both the bulk population and single cell level to uncover
the regulatory axes that govern γδ versus αβ lineage development. The Genomics Core leverages the genomics
expertise of Core Director Dr. Ciofani, who together with bioinformatics collaborator Dr. Timothy Reddy, is
uniquely positioned to provide standardized assay and analytical support for RNA-seq, ChIP-seq, CUT&RUN,
ATAC-seq, in addition to single cell genomics (e.g. CITE-seq, TCR repertoire analysis, scATAC-seq, and
multiomics). With the anticipated development of new genomics modalities and capabilities, the Genomics Core
will also continue to develop new computational pipelines to keep pace with technological advances. In particular,
the Core will establish bioinformatic tools for a novel single cell high-throughput reporter activity assay
(scSTARR-seq) developed by Project 2 and applied to both human and mouse models (Projects 1, 2, 3) to
identify the cis regulatory network (enhancers and silencers) targeted downstream of strong versus weak TCR
signals. Moreover, the Genomics Core will integrate data from multiple orthogonal modalities (i.e. gene
expression, chromatin accessibility, and enhancer reporter activity) to generate regulatory networks for human
and mouse γδ T cell lineage specification. This will facilitate comparative genomics analysis aimed at defining
the shared and divergent regulatory features of mouse and human γδ lineage development. Altogether, the main
objectives of the Genomics Core are (1) training in genomics approaches and bioinformatics analysis, (2)
performing genomics experiments and NGS sequencing of libraries to complete Project Aims, (3) bioinformatic
analysis of global and single cell genomics assays, (4) standardization of experimental and analytical methods,
and (5) facilitating data sharing and accessibility. Taken together the training, experimental, and bioinformatic
efforts of the Genomics Core will facilitate an unprecedented understanding of γδ versus αβ lineage commitment
and provide a valuable resource for the field.